Biospecimens Accessioning and Processing Shared Resource

BIOSPECIMENS ACCESSIONING AND PROCESSING SHARED RESOURCE: ABSTRACT
The Biospecimens Accessioning and Processing Shared Resource (BAPSR) is an enterprise-wide resource with
activities provided at Mayo Clinic in Rochester (MCR), Mayo Clinic in Florida (MCF), and Mayo Clinic in Arizona
(MCA). The BAPSR laboratory provides pre-analytical processing and storage of all types of biospecimens to
support the translation of scientific discoveries into clinical practice. BAPSR’s electronic biospecimens
accessioning and tracking, combined with a broad range of specimen processing services, have created a
powerful, synergistic resource that is invaluable in supporting the Mayo Clinic Comprehensive Cancer Center’s
(MCCCC’s) basic, translational, and population science, as well as clinical research. Three Specific Aims support
this goal:
Aim 1: Expand BAPSR services and processing standards for improved Cancer Center clinical trials and study
support. This expansion will ensure better alignment with sponsor requirements while preserving the necessary
quality.
Aim 2: Foster preferred partnerships between Mayo Clinic BAPSR and clinical trial sponsors. Preferred
partnerships will be based on mutually agreed processing standards, which will streamline the activation process
of clinical trials and minimize protocol deviations.
Aim 3: Harmonize the BAPSR project request process to a single three-site application. This streamlining will
improve quality, reduce activation turnaround time, and broaden available services through enterprise-wide
support for clinical trials and the needs of Disease Groups.
BAPSR provides over 50 services to MCCCC members across the three Mayo Clinic sites, and the MCR and
MCF laboratories are accredited by the College of American Pathologists. BAPSR major services include:
1) Biorepository Customer Support assists investigators in developing new research protocols by consulting on
specimen collection, processing, and providing budget estimates; 2) Sample Intake provides accessioning and
manual processing services; 3) Sample Processing offers automated processing services and also
cryopreserves and stores peripheral blood mononucleated cells; 4) Nucleic Acid Extraction extracts DNA and
RNA, and provides plating services (currently available only at MCR); and 5) Shipping and Storage builds kits,
pulls samples, and handles the shipping and storage of samples.
Member Utilization 2019-2023: 291 Total (30 CPCS, 27 REDI, 23 CGSM, 44 CII, 56 NTTM, 111 ACTS)
Publication by Members: 361, 143 with Impact Factor >10